Driving Biomedical Projects

Abstract: Driving Biological Projects. DBPs ensure that the TRDs address challenges posed by ongoing,
funded research on important biomedical problems. The DBP applications include protein structural biology,
NMR relaxation studies of biomolecular dynamics, and NMR metabolomics, including a clinical project. The
DBPs present challenges that can be addressed using computation as well as offering opportunities for greater
advances enabled through novel software and high-performance computation. While the challenges for clinical
metabolomics projects are similar to other metabolomics projects, clinical projects have regulatory burdens
associated with protected health information (PHI). Developing a HIPPA-compliant instance of NMRbox
presents new challenges, but extends the utility of NMRbox to a new constituency, investigators employing
NMR in clinical settings.
!